Antibodies as Drugs

? DESCRIPTION (provided by the applicant): Support is requested for a Keystone Symposia meeting entitled Antibodies as Drugs, organized by Peter D. Senter, Anna M. Wu, Alan J. Korman and Karl Dane Wittrup. The meeting will be held in Whistler, British Columbia, Canada from March 6-10, 2016. Monoclonal antibodies have had a pronounced impact in medicine and biology, with a broad array of approved agents that are used for the diagnosis, treatment and characterization of cancers, immunological disorders, and infectious diseases. Because of their exquisite target specificities, together with their favorable pharmacologic properties, antibodies are destined to have even increased clinical impact, particularly in diseases that are understood at the molecular level. This Keystone Symposia meeting will focus attention on many of the key advances in antibody-based technologies as well as on where the field is heading. Some of the critical topics that will be include: 1) Antibody structure and function; 2) Engineered antibodies and antibody-like molecules for improved efficacy; 3) Antibody pharmacologic properties and biologic distribution; 4) Antibody-based therapies for cancer and infectious diseases; 5) Targeting co-stimulatory pathways and immunological checkpoints; 6) Antibodies as carriers of drugs, cytokines, radioisotopes and imaging agents; 7) Antibody mimetics; and 8) Clinical advancements and challenges. This meeting has become an established forum that attracts both new investigators and leaders in the field, coming from academia, industry and research institutes around the globe. The goals of the meeting will be to address the critical issues facing the broad field of antibody-based therapeutics, provide an overview of recent advances and bring together interdisciplinary groups for the generation of new ideas and promising areas of investigation. Opportunities for interdisciplinary interactions will be significantly enhanced by te concurrent meeting on Cancer Vaccines: Targeting Cancer Genes for Immunotherapy, which will share two plenary sessions with this meeting. The general topic of this meeting is relevant to the NIAID mission given the strong emphasis the meeting will have on immunological mechanisms for the treatment of cancer and other diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: Antibodies and antibody-like molecules are unique in their abilities to modulate the immune system, as evidenced by approved drugs such as ipilumumab, nivolumab, pembrolizumab, the many drugs that are in various stages of clinical development, and cell-based therapies that incorporate antibodies as targeting components. The Keystone Symposia meeting on Antibodies as Drugs will cover new developments in these areas, focusing not only on underlying principles and requirements for antibody delivery, but also on how antibodies can be optimized, modified, and exploited for therapeutic activity. Opportunities for interdisciplinary interactions will be significantly enhanced by the concurrent meeting on Cancer Vaccines: Targeting Cancer Genes for Immunotherapy, which will share two plenary sessions with this meeting.